Bone marrow-derived myeloid cell dysregulation in malignant progression of glioma

Project Summary
Low-grade gliomas (LGGs), a heterogeneous group of primary central nervous system tumors, are one of the
most common solid tumors in the adolescent and young adult (AYA) population. LGGs can progress to high-
grade gliomas (HGGs) via a process known as malignant transformation (MT), resulting in dismal prognoses.
The mechanisms driving MT of LGG remain poorly understood. In contrast to LGGs, we and others have shown
that HGGs have increased levels of bone marrow-derived myeloid cells (BMDMs) and myeloid-derived
suppressor cells (MDSCs) in peripheral circulation, with an intra-tumoral enrichment of tumor-associated
macrophages (TAMs) and a paucity of CD8+T and natural killer (NK) cells. Although myeloid cells are known to
accumulate during glioma progression, it remains unclear if these cells have a causal role in driving MT. Central
hypothesis: Reductions in anti-tumor reactive CD8+T and NK cell-dependent immune surveillance are
responsible for LGG to HGG malignant transformation in AYA patients and these reductions are dictated by
increased infiltration and immune suppressive activity of tumor infiltrating BMDMs. We have identified two
independent myeloid associated pathways that are responsible for these BMDM phenotypes and we propose to
test the central hypothesis through the following two aims: Aim 1. Delineate the dependency of BMDM cell
differentiation on inhibitor of DNA binding protein 2 (ID2). Using AYA RCAS/tv-a glioma mouse models, we will
knockdown ID2 in BMDMs before and during MT. We will examine effects on pro-tumoral myeloid cells and
evaluate intra-tumoral T and NK cells and mobilization in blood, spleen, and bone marrow at various times with
scRNAseq, mass cytometry, and fluorescent-activated cell sorting. We will also leverage digital spatial
transcriptomics (DSP) in ID2 modulated tumors and validate ID2 signaling in human paired LGG /HGG samples
to dissect the expression of myeloid, NK, T cell markers, and checkpoint molecules to illuminate ROIs critical to
MT. Results will illuminate ID2 mechanisms of BMDM cell differentiation to pro-tumoral myeloid cells. Aim 2.
Determine if the CD74/macrophage migration inhibitory factor (MIF) axis regulates BMDM cell differentiation
during LGG malignant transformation. We will investigate CD74’s role in MT using pharmacological treatments
or transplant wild-type or CD74 KD/KO bone marrow cells in a murine RCAS/tv-a glioma model. We will analyze
peripheral blood and the glioma TME using scRNAseq, mass cytometry, and FACS. We will validate findings with
bulk RNA sequencing data on paired LGG/HGGs from AYA patients and investigate how CD74/MIF signaling
drives reduced T and NK cells which supports LGG MT. We will also leverage DSP in CD74/MIF modulated
tumors and validate CD74 signaling in human paired LGG/HGG samples to dissect the expression of myeloid,
NK, T cell markers, and checkpoint molecules to illuminate ROIs critical to MT that will indicate potentially
targetable vulnerabilities. Overall Impact: Our studies will illuminate novel insights that may enable us to translate
into enhanced immune surveillance approaches to delay and/or prevent MT for AYA LGG patients.

Public health relevance
Low-grade gliomas (LGG) predominantly affect adolescent and young adult (AYA) patients and two thirds of these patients experience malignant progression and lethal outcomes given we have no effective strategies or treatments to predict or prevent malignant progression. We discovered that current treatment failures are associated with the accumulation of immunosuppressive myeloid cells from the bone marrow, which evolve to impair the function of anti-tumor immunity. With this study, our goal is to develop novel immune surveillance approaches for AYA patients with LGGs at risk for malignant progression.